Anesthesiology & Perioperative Medicine Training Grant

Project Summary: This competitive renewal application (T32GM086270) seeks funding for years 16-20 of our
successful T32 postdoctoral training program in anesthesiology and perioperative medicine research training at
the University of Washington. Our primary objective is to provide in-depth research training at the postdoctoral
level in cutting edge (and emerging) areas of biomedical science related to anesthesiology and perioperative
medicine. Prior and current trainees have demonstrated success in this program, producing numerous peer-
reviewed publications, presenting at scientific conferences, achieving research honors and awards, attaining
NIH career development and R01 grant funding, and achieving academic promotion and leadership positions.
We propose training of three fellows per year who will spend 2-3 years cumulative time in research in one of a
variety of laboratories in the Department of Anesthesiology and Pain Medicine or in collaborating basic science
and clinical departments (e.g., Pharmacology, Genetics, Pediatrics, Psychiatry). Research opportunities are
offered by 26 NIH-funded faculty mentors with proven records of success in the training of postdoctoral fellows,
with diverse research programs ranging from laboratory-based science to translational, clinical, and health
services research. Core faculty research leaders will help match trainees to mentors within five major research
areas relevant to anesthesiology and perioperative medicine including (alphabetically): 1) cardiovascular and
mitochondrial biology, 2) clinical outcomes research & epidemiology, 3) genome sciences, 4) neurosciences,
and 5) pain. Aims of the program are: to recruit outstanding diverse postdoctoral trainees from a national
applicant pool; provide trainees with interdisciplinary theories and methods pertinent to their research area;
provide trainees with the practical skills to design and conduct high quality research in anesthesiology and
perioperative medicine (including fundamental research skills, understanding responsible conduct of research
and rigor and reproducibility, ability to disseminate research findings, and acquire successful grantsmanship
skills and independent funding); and to create a supportive environment through strong mentorship, a breadth
of research opportunities, and collaboration across departments. We offer a robust didactic program to provide
career development skills which includes monthly seminars in grantsmanship, scientific writing, journal
club/special topics, and works in progress as well as a resilience and wellness program. All trainees complete
individualized learning plans with their mentors to set goals for their training. Trainee progress is monitored
regularly with summary findings reported to the departmental training grant appointment and steering
committee responsible for accepting/hiring fellows and following their progress. In addition, an external
advisory committee meets yearly to offer advice to the program directors on all aspects of the training program.
The overall intent of the program is to develop the next generation of clinician scientist leaders in
anesthesiology and perioperative medicine research.

Public health relevance
Project Narrative A crucial need exists for anesthesiology and perioperative medicine investigators with a broad range of theoretical, methodological, and technical knowledge. These attributes are required to advance scientific opportunities from basic, translational, behavioral, population and clinical sciences to novel applications that reduce the burden placed on patients and their families by pain, stress, and perioperative complications.